SOAT1 as a targetable dependency in Pancreatic Adenocarcinoma

ABSTRACT
Pancreatic ductal adenocarcinoma (PDAC) is a devastating disease that is notoriously refractory to treatment.
High mortality is driven by late diagnosis, aggressive metastasis, and resistance to both cytotoxic and targeted
therapies, making the development of new treatment strategies essential. To interrogate the molecular drivers
of aggressive PDAC biology and identify new therapeutic targets, we developed mouse and patient-derived
organoid models of progressive disease. In recent work, we leveraged these models to find that the non-essential
enzyme SOAT1 (Sterol-O-Acyl transferase 1) is enriched in invasive, metastatic organoids where it promotes
the hyperactivation of the mevalonate or cholesterol synthesis pathway. SOAT1 esterifies free cholesterol for
storage, disrupting feedback inhibition and leading to increased production of important metabolic byproducts
including isoprenoids, which are required for KRAS prenylation, membrane localization, and activation. Genetic
ablation of SOAT1 markedly suppressed tumor growth in the transplant setting, designating SOAT1 as a robust
therapeutic target in PDAC. SOAT1-deficient PDAC cells also had an impaired ability to migrate, invade, survive
and metastasize. Thus, we hypothesize that SOAT1-mediated MVA pathway hyperactivation stimulates multiple
pathways that collectively enable the invasion of preneoplastic PanIN cells during disease initiation, and promote
the metastasis of established PDAC cells. Here, we will use genetically engineered mouse models to test the
effect of Soat1 deletion on PDAC development and metastasis. Further, we will leverage inducible degron
models to conduct in-depth characterization of the metabolomic impacts of SOAT1 ablation (Aim 1). Our ultimate
goal is to translate these biological findings into new PDAC treatment strategies. To this end, we will use click
chemistry and molecular dynamics simulation to develop first-in-class small molecules that function as potent
and selective covalent-binding antagonists of SOAT1 (Aim 2). Using orthotopic and metastatic transplants of
patient-derived organoids in parallel with autochthonous mouse models, we will comprehensively evaluate the
efficacy of lead SOAT1-inhibitory compounds as monotherapy or combination therapeutic agents in the
prevention of both early PDAC development and metastasis in vivo (Aim 3). Together, the studies outlined here
will provide an exhaustive assessment of the biological role of SOAT1 and the mevalonate pathway across the
stages of PDAC development, using both definitive genetic models and pharmacological approaches. These
results will define the stage-specific utility of SOAT1 antagonism as an exciting new therapeutic avenue in PDAC,
and ultimately yield potent and selective covalent SOAT1 inhibitors that may have direct translational relevance
for PDAC treatment.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is a devastating and treatment-refractory disease for which mortality remains high and new treatments are needed. We recently reported that the enzyme sterol-O-acyltransferase or Soat1 promotes pancreatic cancer proliferation by hyperactivating the mevalonate pathway in advanced cancers. Here, we investigate the biological and molecular mechanisms that Soat1 uses to promote pancreatic cancer; design the first SOAT1 targeted chemical degraders using click chemistry; and determine whether the SOAT1 degraders can prevent pancreatic cancer initiation and metastasis in model systems.